Cellular lipid transport determined with multifunctional lipid derivatives

Project Summary
In our current R01 project, we use multifunctional lipid derivatives to identify lipid binding proteins and to
determine lipid location inside intact cells. The latter we use to study lipid transport from one cellular membrane
system to another. Explicitly, we investigate new putative lipid transport proteins and their role in cell signalling
and function. We identified two proteins, the cytosolic MPP6 and the plasma membrane-associated ATP11A.
The summer student will prepare single residue mutants of MPP6 and isolate the mutant proteins. The student
will investigate the influence of the mutants on lipid binding by using lipid strips and changes in lipid transport
by replacing the endogenous MPP6 by the mutant variety via the CRISP/CAS9 technique. Time permitting the
student will also prepare the first GFP fusion proteins of ATP11A. The candidate Ms. Amelia Kotamarti has
experience in cloning techniques and tissue culture and is familiar with our fluorescent laser-scanning confocal
microscope. The student will be supervised by an experienced technician, Mr. Andrew Gustafson. The student
will participate in our group meetings, and lab activities as well as in the Summer Undergraduate Research
Program (SURP) of the Department of Chemical Physiology and Biochemistry.

Public health relevance
Project Narrative In recent work, we identified proteins that are involved in transporting lipids from one cellular membrane to another. Within the funded research program, we are investigating lipid specificity and lipid-protein interactions to better understand the transport process. The summer student will participate preparing novel mutants of the transport proteins and in visualizing lipid transport by fluorescence microscopy.